Project 3: Neural Encoding of the Incentive Value Attributed to Food and Drug Cue

PROJECT SUMMARY (See instructions): Cues associated with food and drug rewards acquire 1) predictive properties, and the ability to evoke conditioned responses, and 2) incentive properties, and thus the ability to attract, reinforce, and motivate behavior. These latter properties may be especially important in the development of compulsive behavioral disorders, including addiction. However, predictive cues do not necessarily have the ability to act as incentive stimuli. In fact, there are substantial individual differences in the ability of cues to influence behavior. For example, while some people are able to use drugs casually throughout their lifetime, others become addicted, having difficulty remaining abstinent, especially in the presence of people, places, and other cues associated with drug-taking. By examining the behavioral responses to food cues, we have identified rats that attribute incentive value to these cues (sign-trackers), and are more sensitive to the effects of drug cues on drug-taking behavior and relapse. In contrast, goal-trackers do not attribute incentive value to food cues and are unaffected by drug cues. Studies of cue-evoked changes in brain activity have found that ventral regions of the basal ganglia (including the nucleus accumbens [NAcc] and ventral pallidum [VP]) process information related to both food and drug cues. However, until recently, it has been difficult to delineate what aspects (i.e., predictive or incentive) of these cues are processed, and whether the processsing of incentive value is altered by abused drugs. The experiments described within this proposal will utilize individual differences of sign- and goal-trackers to determine whether the NAcc and VP process incentive vs. predictive properties of food cues in sign- and goal-trackers, and to what extent the neurochemical dopamine is involved. To this end, we will measure the neural response to cues in Pavlovian and drug self-administration experiments using in-vivo single-unit recordings. Our overall hypothesis is that VP and NAcc neurons will be more responsive to the incentive properties than to the predictive properties of reward cues when presented within these experiments.

Public health relevance
RELEVANCE (See instructions): Some people use drugs casually; others become addicted and have difficulty remaining abstinent in the presence of cues associated with drug-taking. We will compare the brain's responses to various cues in rats that are either susceptible or resistant to the effects of these cues. These experiments will help explain the sensitivity to food- and drug-related cues and lead to interventions to reduce their impact on drug-taking.